Using Brain Lesions and Deep Brain Stimulation to Identify an Epilepsy Circuit

PROJECT SUMMARY: Using brain lesions and deep brain stimulation to identify an epilepsy circuit
Focal epilepsy is common in patients with brain lesions such as stroke, trauma, and tumors. Why some patients
with brain lesions develop epilepsy while others do not is unknown. Deep brain stimulation (DBS) offers new
therapeutic promise for patients with focal epilepsy, but seizure freedom is rare. Why some patients improve
after DBS while others do not is also unknown. Current dogma focuses on the lesion location or DBS site alone.
We hypothesize that connectivity of lesion locations and DBS sites to remote nodes distant from the lesion or
DBS sites itself can explain variance in lesional epilepsy and DBS response.
New techniques developed by the Fox lab (PI) can identify remote nodes connected to lesions causing
and DBS sites treating brain diseases. These techniques combine the location of the lesion or stimulation site
with a normative atlas of human brain connectivity termed the connectome. As such, they do not require
connectivity data from the patients themselves and can be applied to almost any clinical lesion or DBS dataset.
This approach has successfully mapped circuits involved in parkinsonism, amnesia, depression, and over 20
other brain diseases. Moreover, identifying circuit nodes connected to both lesions causing and DBS sites
treating the disease can identify new or improved therapeutic targets.
Our preliminary data in ischemic stroke suggests there is a common brain circuit involved in epilepsy.
Lesion locations that cause epilepsy (n = 76) are more connected to the cerebellum and basal ganglia (‘Ce-BG’)
compared to control lesions (n = 625). Connectivity of anterior thalamic DBS sites to these same circuit nodes
is correlated with seizure reduction after DBS (n=30). While epilepsy is often considered a cortical disease, these
subcortical Ce-BG nodes have previously been implicated in the modulation of seizures and cortical excitability.
Although promising, further work is needed to determine if these results generalize across lesion types (Aim 1,
n = 2,700), prospectively predict epilepsy risk (Aim 2, n = 6,000), and correlate with DBS response (Aim 3, n =
198). For each aim, we will focus on our Ce-BG nodes as an a priori hypothesis, but also perform data-driven
(unbiased whole-brain) analyses to minimize risk of false positives or negatives. We will perform all analyses
using a functional connectome (primary outcome) and structural connectome. Completion of these aims will
determine whether connectivity of lesion locations and DBS sites to a common set of subcortical nodes can
explain variance in lesional epilepsy and DBS response. Identifying this circuit could identify patients at high risk
for epilepsy, guide DBS programming, and serve as a target for future brain stimulation trials. Collectively, these
results could facilitate a shift in focus from the seizure-onset zone itself, which differs in every patient, to a brain
circuit that may represent a new therapeutic target for focal epilepsy.

Public health relevance
Using brain lesions and deep brain stimulation to identify an epilepsy circuit Focal epilepsy affects over 30 million patients worldwide and identifying the brain circuits involved in epilepsy can lead to better, more targeted treatments. Here, we use maps of human brain connectivity and a technique recently developed by our lab to identify the brain circuits connected to lesions causing epilepsy and brain stimulation sites treating epilepsy. Identification of these circuits will help identify lesion patients at highest risk for epilepsy, guide DBS programming, and provide a more precise therapeutic target for future brain stimulation trials.